A continuous evolution platform for cyclic peptide discovery

Project Summary
Cyclic peptides have attracted enormous interest as research tools and therapeutics because they can inhibit
historically difficult to drug targets such as protein-protein interactions. In vitro display methods for cyclic
peptide discovery have proven highly successful in identifying potent inhibitors but are generally restricted to
the selection of binders to purified and immobilized target proteins. A second approach is to use cellular
selections to discover new cyclic peptides, which can possess advantages that complement some drawbacks
of in vitro methods, such as the ability to select for more complex inhibitory activities, the lack of requirement
for purified target protein, and the ability to identify cyclic peptides active in the complex cellular environment.
However, the current technology for cellular cyclic peptide selection has notable limitations such as smaller
library sizes, lower hit potencies, lack of counter-selection to weed out promiscuous hits or false positives, slow
rate of selection, and limited non-canonical amino acid incorporation.
To advance the state of the art of cellular cyclic peptide discovery, we propose a new platform for cyclic
peptide selection based upon phage-assisted continuous evolution. We demonstrate a working system that
uses an activity-based selection for inhibiting target protein aggregation in cells and can employ negative
selection to purge promiscuous hits and false-positives. We will augment our platform with additional activity-
based selections for both inhibitors and inducers of protein-protein interactions, develop methodology for
continuous in vivo mutagenesis that will address library size limitations of cellular selections, and incorporate
non-canonical amino acids that enable the biosynthesis of both side-chain and backbone modified cyclic
peptides to improve the diversity and potentially bioavailability of cyclic peptides identified through our platform.
If successful, this work will provide a powerful new platform for selecting structurally diverse cyclic peptides
with a wide range of inhibitory activities.

Public health relevance
Project Narrative Cyclic peptides represent a promising source of therapeutics for inhibiting disease targets historically considered “undruggable.” Widely used methods for cyclic peptide discovery rely predominantly on binding to immobilized protein targets, making it challenging to select directly for hits with inhibitory activity in a cellular context. We propose to establish a new platform for selecting structurally diverse cyclic peptides with a wide range of inhibitory activities in cells.